Supplemental funding for ROTR-CHEM-1005 Development of Human-Relevant Small Animal Models of Sulfur Mustard Toxicities

The primary objective of this IAA is to develop human relevant animal models following sulfur mustard (SM) exposure that could potentially be utilized as a screening tool to identify novel medical countermeasures. The ultimate goal as such is to develop in vivo models that could support the research and early development of MCMs against the highly toxic vesicating chemical warfare agent sulfur mustard. Animal models following sulfur mustard exposure will provide important information on mechanism of action, for the chemical threat agent, therefore understandings about various major organ damages such as ocular, pulmonary, cutaneous, hematopoietic, gastrointestinal, hepatic and neurological. Areas of interest may include: (1) Establishing natural history and mechanisms of action of major pathophysiological damages due to sulfur mustard exposure; (2) Designing and executing efficacy screening of various candidate therapeutics; and (3) Analyses and interpretation of all research findings, and (4) Preparation of study reports, poster/oral presentations, and manuscript publications related to the executed studies.